Oklahoma Shared Clinical and Translational Resources

ABSTRACT
The integration of electronic health records (EHR) and the analysis of real-world data (RWD)
have significantly advanced clinical and translational research (CTR), although challenges
persist in data granularity and expertise. To address these, the University of Oklahoma Health
Sciences Center (OUHSC) aims to expand data science infrastructure and foster cross-
disciplinary partnerships to leverage RWD resources. This proposal, submitted as an
administrative supplement to the Oklahoma Shared Clinical and Translational Resources
(OSCTR) award, aligns with efforts to address health disparities in Oklahoma, focusing on
prevalent issues such as cancer, diabetes, and substance abuse. By enhancing text analytics
capacity and promoting collaboration between clinical and data science experts, the project
seeks to expedite research efforts and position OUHSC as a leader in health-focused data
science. Unique intercampus partnerships and innovative approaches, such as AI-assisted
information retrieval, promise to revolutionize CTR research at OU, ensuring Oklahoma
remains at the forefront of healthcare practice and research innovation.

Public health relevance
Project Narrative. The integration of electronic health records (EHR) and analysis of real-world data (RWD) have revolutionized clinical and translational research (CTR), with significant implications for public health. However, gaps in data granularity and expertise have hindered scientific breakthroughs, delaying progress. The University of Oklahoma Health Sciences Center proposes to expand data science infrastructure and foster cross-disciplinary partnerships to address these challenges, aiming to accelerate research efforts and position Oklahoma as a leader in health data innovation.